DETERMINATION OF FIRST PASS INTESTINAL METABOLISM OF MIDAZOLAM IN HUMAN SUBJECTS

To estimate the intestinal contribution to the first pass metabolism of orally administered midazolam. The hypothesis is that midazolam is metabolized by intestinal cytochrome P450 3 A (P450 3A) enzymes to a clinical significant amount. To measure the effect of P450 3A inhibition by orally administered ketoconazole on the pharmacokinetic parameters of orally and intravenously administered midazolam. The hypothesis is that oral ketoconazole affects the disposition of the oral more than that of the intravenous midazolam.